Structures and mechanisms of transmembrane receptors

Abstract
Transmembrane receptors are the major mediators of signaling for cells to communicate with the
environment, playing essential roles in many cellular processes, including migration, proliferation and
immunity. Malfunction of these receptors are associated with diseases such as cancer and neurological
disorders. The long-term goal of this research program is to understand the general mechanisms by which
signal is transduced from one to the other side of the membrane through the transmembrane region of
receptors, in particular single-pass transmembrane receptors. On the other hand, each receptor has its own
unique properties and mechanisms. We also study the individual characteristic features of these receptors,
especially larger assemblies beyond the ligand-induced dimeric receptor paradigm. A better understanding of
the transmembrane signaling mechanisms of these receptors will lay the foundation for the development of
targeted therapies for associated diseases. We use structural approaches, including both cryo-EM and X-ray
crystallography, in combination with in vitro biophysical and biochemical analyses and cell-based functional
assays. In the past, we had focused mostly on plexin, the largest family of guidance receptors critical for the
development of the nervous and cardiovascular systems. Plexin activated by the semaphorin ligand
transduces repulsive signal to steer the growth cone of the neuron for the formation of the neuronal network.
Plexin is also critical for regulating immunity and wound healing. In the next few years, one major goal of the
work on plexin is to understand how the transmembrane regions of plexin and its co-receptor neuropilin couple
the extracellular ligand-binding region and the intracellular effector region for precise controlling of signaling
across the plasma membrane. In particular, we will analyze novel regulatory mechanisms endowed by large
assemblies of semaphorin, plexin and neuropilin. In addition, we will expand our work to other receptors
involved in the neuronal, cardiovascular and immune systems. For example, neuropilin also serves as a co-
receptor for VEGF receptor (VEGFR), a receptor tyrosine kinase essential for vasculogenesis and
angiogenesis. Neuropilin can dramatically increases the potency of VEGF in activating VEGFR. We will
analyze the mechanism of the signaling enhancing effect of neuropilin on VEGFR. The functions of
semaphorin also extent beyond plexin. Red blood cell-derived Sema7A binds GPIb, a protein complex
specifically expressed on platelets, and thereby stimulates thrombo-inflammation in myocardial ischemia-
reperfusion injury. GPIb contains transmembrane receptors GPIbα, GPIbβ and GPIX in a 1:2:1 stoichiometry.
The best-known function of GPIb is triggering platelet activation in response to VWF (von WilleBrand Factor),
vital to hemostasis. We will analyze how Sema7A and VWF bind GPIb and how the binding induces the
activation of GPIb.

Public health relevance
Project Narrative Transmembrane receptors are the major mediators of signaling for cells to communicate with the environment, playing essential roles in many cellular processes. Malfunction of these receptors can cause diseases such as cancer and neurological disorders. The goal of this research program is to understand the structures and mechanisms of these receptors, paving the way for developing targeted therapies for diseases associated with these receptors.